A real-time monitoring and predictive device for cardiovascular surgeries and sepsis

Abstract
Sepsis is a life-threatening condition that occurs when the body's response to an infection damages its tissues
and organs. It can quickly progress to septic shock, leading to multiple organ failure (heart, lung, kidney) and
death. Sepsis is often difficult to recognize in emergency departments and intensive care units because it is a
milieu of nonspecific symptoms, and a rapid diagnosis enabling earlier intervention could save many lives and
preserve heart and lung function as myocardial depression occurs in 50% of patients with sepsis. The current
diagnosis of sepsis requires a complex evaluation of signs and symptoms, identification of the infection source,
and laboratory tests to assess systemic inflammation and organ dysfunction. The team has performed sepsis-
animal studies and probed the diagnostic accuracy of sepsis through urine biomarkers of hypoxia. Other
biomarkers in blood, such as arterial blood gas pH and lactate, can be used to monitor a patient's sepsis
response to treatment. However, due to the invasive nature of blood sampling and associated safety
requirements, sepsis diagnosis typically occurs in hospital laboratories. Urine analysis is a non-invasive method
for diagnosing various diseases and is suitable for sepsis detection. A timely sepsis diagnosis without a blood
test would represent a significant breakthrough in the medical field. Due to the invasive nature of blood analysis,
arterial blood gas pH or lactate clearance is typically assessed over hours to a day rather than minutes.
Continuously monitoring of urine sepsis biomarkers enables the patient's sepsis early diagnosis within minutes
(less than 200 minutes), not several hours to a day.
The team will develop a continuous, real-time, automated Smart Catheter Analyzer for early identification of
sepsis through urine biomarkers to enable clinicians to respond quickly to support heart and lung function. It is
envisioned that the device will be used by minimally trained personnel in emergency departments, urgent care,
rural emergency services, intensive care units, and out-of-hospital settings. The team, comprised of sensors,
engineering, computer science, medical and clinical research, and medical device industry/manufacturing
expertise, will work to design and develop the Smart Catheter Analyzer for sepsis-related urine biomarkers in a
2-year R61 (Phase I) and to further develop and refine the Smart Catheter’s Algorithm for Sepsis in a 1-year R33
(Phase II). The device prototype developed in Phase I at Arizona State University will be used in a study during
Phase II at Mayo Clinic Arizona, comparing noninvasive biomarker patterns in septic and non-septic cases.
Industrial partner, Sequitur Health Corp., will contribute to the acceleration of the technology towards practice.
This project will enhance medical personnel's technical capabilities for the diagnosis and treatment of sepsis and
enable gains of scientific knowledge for heart and lung-related functions.

Public health relevance
Narrative The proposed novel device is capable of continuous, quantitative, monitoring of urine in already catheterized in-hospital patients , which can be leveraged for new clinical detection, possible prevention, and improved management of downstream varied heart and lung disorders related to sepsis. In the short term, development of this new measurement platform will enable non-invasive, clinically relevant diagnosis and monitoring for heart and lung disorders related to sepsis. In the long term, this platform will enable new studies of therapies and interventions to improve outcomes and reduce incidence of heart and lung disorders related to sepsis.